Quantitative Analysis of Serum Autoantibody Repertories in Systemic Lupus Erythematosus

SUMMARY
Systemic Lupus Erythematosus (SLE) is a multi-organ, systemic autoimmune disorder, estimated to affect at
least 1.5 million Americans. The hallmark of SLE is the production of serum autoantibodies, a unifying feature
present in over 99% of untreated patients. Such autoantibodies are directly pathogenic, eventually causing the
symptoms of SLE including debilitating joint pain and rashes, followed by organ damage and early mortality.
Previous work has shown that autoantibodies begin to accrue months to years before the symptoms of SLE
appear which may allow a window for detecting them and starting medications to prevent or at least delay the
onset of SLE. These serum autoantibodies, however, consist of a complex mixture in the blood including
pathogenic, non-pathogenic, and beneficial antibodies which may number in the millions. While current
diagnostic platforms can screen for total autoantibodies during autoimmune disease, finding specific
monoclonal autoantibodies linked to the development of SLE is currently impossible. Thus, the lack of
capability to directly detect monoclonal, pathogenic, autoantibodies presents a significant barrier in
understanding how autoantibodies arise, and there is a critical need to develop advanced analytical tools to
characterize these antibodies. Our long-term goal is to understand SLE autoantibody development at the
monoclonal level and to develop high diagnostic value autoantibody biomarkers. The overall objective of this
proposal to establish a novel integrated proteomics platform that employs two complementary scientific
approaches, a quantitative top-down MS approach for autoantibody biomarker discovery, and a top-down
proteogenomics sequencing approach for autoantibody biomarker validation and functional characterization.
Our proposed top-down autoantibody proteomics platform will be applied to identify intact autoantibody Fab
signatures in longitudinal SLE serum samples. As a result, we will provide a first top-down proteomics platform
for characterizing SLE autoantibodies at the monoclonal level. Applying it to the analysis of SLE
autoantibodies will provide foundations for new strategies in SLE prognosis, intervention, and prevention, and
may lead to novel high diagnostic value biomarkers. After development, our top-down autoantibody
characterization platform can be easily adapted to other autoimmune diseases such as Sjogren’s Syndrome.

Public health relevance
PROJECT NARRATIVE The overall objective of this proposal is to develop a novel top-down proteomics (i.e., starting with intact proteins) platform to screen the entire serum autoantibody repertoire and to sequence antigen specific autoantibodies in longitudinal Systemic Lupus Erythematosus (SLE) sera samples. As a result, we will provide the first snapshot of SLE autoantibody development at the monoclonal level, which may lead to high diagnostic value biomarkers and provide foundations for new strategies in SLE prognosis, intervention, and prevention.